Environmental Localization Mapping and Guidance for Visual Prosthesis Users

Environmental Localization Mapping and Guidance for Visual Prosthesis Users
Project Summary
About 1.3 million Americans aged 40 and older are legally blind, a majority because of diseases
with onset later in life, such as glaucoma and age-related macular degeneration. Second Sight
developed the world’s first FDA approved retinal implant, Argus II, intended to restore some
functional vision for people suffering from retinitis pigmentosa (RP).
In this era of smart devices, generic navigation technology, such as GPS mapping apps for
smartphones, can provide directions to help guide a blind user from point A to point B. However,
these navigational aids do little to enable blind users to form an egocentric understanding of the
surroundings, are not suited to navigation indoors, and do nothing to assist in avoiding obstacles
to mobility. Prosthetic vision devices like the Argus II, on the other hand, provides blind users with
a limited visual representation of their surroundings that improve users’ ability to orient themselves
and traverse obstacles, yet lack features for high-level navigation and semantic interpretation of
the surroundings. The proposed research aims to address these limitations through a synergy of
state-of-the-art simultaneous localization and mapping (SLAM) and object recognition
technologies.
This proposal is driven by the hypothesis that navigation for users of retinal prosthetics can be
greatly improved by incorporating SLAM and object recognition technology conveying
environmental information via a retinal prosthesis and auditory feedback. SLAM enables the
visual prosthesis system to construct a map of the user’s environment and locate the user within
that map. The system then provides object location and navigational cues via appropriate sensory
modalities enabling the user to mentally form an egocentric map of the environment. We have
developed an advanced visual prosthesis system which 1) constructs a map of unfamiliar
environments and localizes the user using SLAM technology 2) automatically identifies the
structural semantics of the surroundings to determine navigationally-relevant obstacles and
features and 3) provides sensory feedback for navigation, obstacle avoidance, and
object/landmark identification. This project focuses on the completion of human subject testing of
these capabilities.

Public health relevance
Environmental Localization Mapping and Guidance for Visual Prosthesis Users Project Narrative The proposed system will use advanced simultaneous localization and mapping, and object recognition techniques, to enable visual prosthesis users with unprecedented abilities to autonomously navigate and identify objects/landmarks in unfamiliar environments.